Dissemination of the Cardiovascular Risk Service (CVRS Live)

Project Summary/Abstract
Cardiovascular disease (CVD) causes 2,200 deaths in Americans every day. Yet effective implementation of
evidence-based interventions that reduce CVD-related morbidity and mortality remains a substantial challenge.
The Patient-Centered Medical Home including self-management, personalized health records, and team-based
care is a strategy to improve care for patients with multiple chronic conditions. Building upon this framework,
we developed an innovative team-based intervention, the Cardiovascular Risk Service (CVRS), which includes
a centralized, pharmacist-led cardiovascular risk service and prevention services (e.g., vaccinations, cancer
screenings) model to support primary care providers with CVD management and achievement of key
performance measures. Results from one of our previous NIH-funded clustered-randomized trials showed a
decrease in CVD risk factors in CVRS intervention patients receiving care through private physician offices.
However, we discovered many more barriers to adoption of the CVRS in large health centers in another
ongoing trial than the major positive support we received in small rural private clinics. Our long-term goal is to
improve CVD management through team-based primary care. The application objective is to test the
scalability of the CVRS in 12 large, organizationally and culturally diverse (diverse) hospitals and health-
systems, many with high proportions of minority and underserved patients, using a pragmatic cluster-
randomized design. Scaling-up the CVRS will require an assessment of adoption, implementation, and
maintenance for broader dissemination and implementation. Our central hypothesis is that barriers and
facilitators to CVRS implementation will vary across diverse primary care offices. We will use a
transdisciplinary approach in collaboration with national experts in educational policy to measure these
variances by means of mixed methods including interviews, observations, and surveys. The proposed study
rationale is a novel implementation approach to improve CVD management and prevention services in
patients with complex medical histories and will lead to innovative strategies for broader adoption by US health
systems. Grounded in the RE-AIM framework, we will accomplish our objective and test our central hypothesis
with these specific aims: Aim 1: Identify, understand, and develop strategies for overcoming barriers to the
adoption, implementation, and maintenance of the CVRS in diverse primary care offices. Aim 2: Determine the
real-world reach and effectiveness of the CVRS in diverse primary care offices. Aim 3: Determine CVRS
sustainability and adaptation in diverse primary care offices. Our approach is innovative because it will ask:
“How can implementation processes be improved and maintained?” as well as “Can implementation and
maintenance be ‘tailored’ to real-world primary care providers so that they desire expansion to underserved
patients?” This study design is novel because it will be the first to evaluate the adoption, implementation, and
maintenance of a behavioral intervention using the comprehensive model in large, complex health systems.

Public health relevance
Project Narrative: This proposed study is relevant to public health because it will develop innovative strategies for the implementation of efficient care for patients living with multiple chronic conditions as well as lead to improved and more comprehensive primary care for this vulnerable population. The proposed research is relevant to the NHLBI research priority to optimize translational, clinical, and implementation research to improve health and reduce disease. The results of this study will help to achieve important milestones for the Million Hearts Campaign and the goals of the American Cancer Society (ACS), American Diabetes Association (ADA), and the American Heart Association (AHA) for their Guideline Advantage program.